Administrative Core

Project Summary
The University of Alabama at Birmingham (UAB)-University of California at San Diego (UCSD) O’Brien
Center for Acute Kidney Injury (AKI) will oversee and manage the day-to-day conduct of the UAB-UCSD O’Brien
Center, including the scientific, enrichment, fiscal, and communications operations and website maintenance.
This Core will collaborate closely with the NIDDK, NCC, Steering Committee, and Consortium that will (i) Provide
logistic, administrative, financial, and scientific oversight to the UAB-UCSD O’Brien Center Cores: assure the
effectiveness, efficiency, and synergy of each of the two Biomedical Resource Cores and the Resource
Development Core to enhance national outreach and impact.; (ii) Foster meaningful interactions and coordinate
with the NCC and the Consortium to prioritize the development of shared, authenticated, and robust resources
important for AKI-related research in addition to ensuring quality assurance/quality control (QA/QC) and rigor
and reproducibility for the Core services.; (iii) Promote diversity of scientists pursuing AKI-related research; (iv)
Promote opportunities that attract early-stage and new investigators to AKI research (v) Collaborate with the
NCC to educate the community about AKI research and (vi) Optimize training and educational opportunities in
kidney research for medical students through a Summer Student Training Program (SSTP. The Administrative
Core will coordinate and integrate the diverse activities of the UAB-UCSD O’Brien Center, facilitate interactions
and collaborations among the research base, ensure quality control, rigor and reproducibility of the core services
and promote scientific development.
The administrative structure with clear lines of authority has been developed to ensure that the goals and
objectives of the Center are achieved. The Director and Associate Directors will make decisions and seek input
as needed from the Steering Committee and the National Coordinating Center (NCC). The Administrative Core
will oversee training and educational programs made available to the community to advance understanding of
AKI-related research.

Public health relevance
Project Narrative As per the RFA, not needed for individual components.